NATIONAL HEALTH AND NUTRITION EXAMINATION SURVEY 2019-2020, NUTRITION QUESTIONNAIRE COMPONENT FOR SURVEY PARTICIPANTS AGE 0 UP TO 24 MONTHS

To provide support to the National Center for Health Statistics (NCHS), for the Nutrition Questionnaire Component for survey participants aged 0 up to 24 months in the National Health and Nutrition Examination Survey (NHAES) and for cognitive testing of the questions prior to fielding. The cognitive testing process begins I 2017 and continues into 2018.